Spectralis Tracking HRA-Optical Coherence Tomography 2 (OCT2): Advanced Ophthalmic Imaging for Small and Large Animal Studies

6. Project Summary/Abstract The proposed Shared Instrumentation Grant (SIG) is submitted for a one-time award to acquire a state-of-the art diagnostic ocular imaging system dedicated to the benefit of vision science research purposes at the University of Pennsylvania. The aim of the project is to replace two outdated, existing pieces of instrumentation with a single platform device. The desired all-purpose system is a SPECTRALIS diagnostic imaging instrument capable of examining both the anterior and posterior poles of the eye. More specifically, it will be used to examine ocular structures of the cornea, iris, lens, inner and outer retina, macula, optic nerve and choroid of both small and large animal models of human ocular disease. From these images quantitative information can be obtained to show disease progression or regression as a result of genetic manipulation or therapeutic treatments in animal models of ocular disease. This system is expected to accelerate pre-clinical research for numerous researchers and their staff involving multiple government, foundation and corporate sponsored projects.

Public health relevance
7. Project Narrative The Spectralis machine is a “state-of-the-art” instrument, providing single cell resolution imaging of the retina and has dual tracking functions, thereby rendering it capable of obtaining high quality images even from animals whose gaze wanders due to sedation or changes slightly in positioning between initial and follow-up imaging sessions. This machine promises to be useful not only for safety measurements, but also for studies of correlations of genotype with phenotype, interventional studies (including gene therapy, small molecule therapy, gene editing, cell transplantation, dietary changes, and environmental exposure manipulations). It is equipped with accessories that can be used to monitor changes in structural architecture like cellular density, apoptosis and degeneration, vasculature and perfusion via angiography, native and exogenous autofluorescence involving inflammatory response, and iridial and corneal status.